Isothermal DNA amplification using double DNA primer

Project Summary
Nucleic acid amplification techniques have revolutionized diagnostics of human diseases. However, the gold
standard, polymerase chain reaction (PCR)-based tests, require specialized laboratories and highly qualified
personnel, which delays delivering test results to patients and health care providers. Existing isothermal
amplification techniques are compatible with point-of-care settings but suffer from low specificity, require complex
primer design and reaction optimization, and have limited multiplexing capabilities. Here, we propose an
alternative isothermal amplification technique to solve the limitation of existing methods for isothermal
amplification. The technique uses a pair of double-stranded primers that can be elongated by DNA polymerases
with strand displacement activity currently used in isothermal techniques (e.g. in LAMP). Each of the two
fragments of the double-stranded primer can start the newly synthesized sDNA strands, which would produce
high concentrations of the amplified DNA. The reaction will produce a double-stranded DNA amplicon of a
defined size, similarly to the products of PCR. The dsDNA amplicon can be detected with sequence-specific
probes in a multiplex format, similar to qPCR. It is expected that the new method will contribute to the
development of accurate, rapid and affordable point-of-care and home tests for diagnosis of human diseases.
The technology can impact other fields including fundamental research, environmental monitoring, food
monitoring and forensic applications, among others.

Public health relevance
Narrative Existing isothermal amplification techniques are compatible with point-of-care settings but suffer from low specificity, require complex primer design and/or optimization of amplification conditions, as well as offer limited multiplexing capabilities. Here, we propose an alternative isothermal amplification technique to solve the limitation of existing isothermal amplification approaches. The new technique has a potential to make point-of- care diagnostics more accurate and lay a foundation for sensitive and easy-to-use home tests for disease diagnostics.